DP24-062 (SIPS), Patient Perspectives on Relabeling and Pathology Reporting for Grade Group 1 Prostate Cancer

PROJECT SUMMARY/ABSTRACT
There is considerable debate about removing the label of “cancer” from low-grade prostate cancer due to its
indolent natural history. A related challenge is the optimal patient-centered presentation of pathology reports in
the era of immediate electronic access to clinical results. A critical research gap is the perspective of diverse
patient populations on prostate cancer nomenclature and pathology reporting. We will address this gap through
3 key approaches: (1) We will perform qualitative studies of patient perspectives on prostate cancer
nomenclature and preferences for a patient-centered pathology report. (2) We will conduct discrete choice
experiments to determine the impacts of changes in nomenclature for low-grade prostate cancer. (3) We will
conduct a randomized study to test the usefulness of alternative wording in pathology reports and of patient-
centered pathology supplements. We will explicitly sample Black, Hispanic, and other men reflecting the broad
geographic and socioeconomic diversity of California. All stages of the study will be conducted in English and
Spanish. Our multi-disciplinary team is well suited to lead this study with expertise in prostate cancer clinical
care, qualitative and quantitative research. Our advisory board includes additional experts in prostate
pathology, biostatistics and patients who will be involved in all stages of the research design and public
dissemination of results. The expected outcomes of this study will advance the field by studying the optimal
prostate cancer nomenclature and pathology reporting in diverse patient populations.

Public health relevance
PROJECT NARRATIVE: There is considerable debate around the optimal nomenclature for low-grade (grade group 1, GG1) prostate cancer, reflecting in part challenges with patient understanding of pathology reports. Recruiting from the diverse, population-based California Cancer Registries (CCR), we will conduct bilingual qualitative studies on patient perspectives about the nomenclature and optimized reporting of low-grade prostate cancer. We will follow this with a quantitative discrete choice experiment and randomized trial among over 500 additional CCR patients to identify consensus preferred nomenclature and patient-centered pathology reporting options.